GROWTH HORMONE SECRETION &BODY COMPOSITION MEASUREMENT IN ADULTS

The purpose of this study is to determine the extent to which body fat, regional distribution of fat, and fitness influence growth hormone (GH) secretion in young, middle-aged, and older adults. These relationships will be examined during spontaneous, fasting and exercise conditions. Body composition will be determined using a 4 compartment model and GH section by frequent sampling. We will also investigate whether the decrease in GH secretion with aging is due to a decrease in GH pulse frequency, amplitude, or some combination of these facts.